The world’s smallest vertebrate brain: A new model for nervous system function and regeneration research

Project Summary / Abstract
Regeneration is widespread and variable in the animal kingdom. Regenerative capacity of the human central
nervous system (CNS) following injury or disease is poor, yet several mechanisms exist in several vertebrate
organisms that lead to functional regeneration of the CNS. What is different between what happens at injury
sites in these organisms and in humans? Are lost neuron types and neuronal wiring patterns restored upon
regeneration of neural circuitry in animals that can achieve this feat? I propose to develop a novel experimental
vertebrate regeneration system that will enable identification of mechanisms that naturally promote nervous
system regeneration. Specifically, I plan to focus on Danionella cerebrum, a miniature and transparent fish
species that has the smallest vertebrate brain on record, with ~650,000 neurons in total. Because of its minute
size, optical transparency, complex behavioral repertoire, and genetic tractability Danionella cerebrum is
potentially unparalleled as a vertebrate for tissue-wide single-cell RNA sequencing (scRNA-seq), and for whole-
body and -brain imaging applications targeted to evaluate cellular dynamics in the adult state. I have two main
aims: In aim 1, I plan to generate a complete Danionella cerebrum scRNA-seq atlas that includes
homeostatic and regenerating states. Generation of a single-cell transcriptome atlas of the whole body of a
vertebrate will be a powerful resource for a myriad of central problems in vertebrate biology and neuroscience.
The proposed resource combined with the small size of the Danionella nervous system will enable utilization of
scRNA-seq experiments in the future to probe a host of problems that involve body-wide manipulation of neural
development and circuit activity, and recovery following injury. This dataset will also allow characterization and
manipulation of circuit components within distinct areas of the central and peripheral nervous system, and will
identify genes with appropriate cell-specific expression to enable genetic cell ablations, cell-specific labeling, and
imaging of regenerating neural circuits. Because of its optical transparency, I have complete access to the
Danionella nervous system for validation and future functional imaging studies. In aims 2 and 3, I propose to
develop strategies to study and manipulate neural dynamics during regeneration, and in the absence of
it (i.e. following inhibition of regeneration). This aim will include generation of cell type-specific nitroreductase
expression-based genetic cell ablation lines, surgical injury strategies, learning and memory paradigms, and a
calcium imaging platform to enable characterization of functional regeneration in the nervous system. Success
with this aim will enable future work elucidating the “rules” for functional integration of new neurons following
acute and chronic ablation in the nervous system. The molecular and cellular insights gained from the proposed
aims will accelerate discovery and understanding of fundamental aspects of neural regeneration with potential
for developing approaches that could be taken to generate therapeutic intervention in the cases of nervous
system injury and degeneration.

Public health relevance
Project Narrative Studies focusing on regeneration within the nervous system hold great potential for the development of therapeutic approaches that aim to generate cures for central nervous system injury and degeneration. In this project, I aim to establish the emerging model Danionella cerebrum – one of the world's smallest vertebrates and a member of a clade of vertebrates (teleost fish) that can regenerate after brain injury – as a novel vertebrate model system for nervous system function, and regeneration research. Combining single-cell RNA sequencing, cell-type-specific ablations, and live calcium imaging will allow study of regeneration in the central and peripheral nervous system, and reveal principles concerning the functional and structural basis of regeneration in specific neural circuits.